3D genome architecture and the origins of recurrent genomic rearrangements in prostate cancer

Genomic rearrangements involving the ETS transcription factor family genes are early driver events in prostate
cancer (PCa). These rearrangements typically involve the fusion of androgen-regulated transcriptionally active
genes with the ETS genes (ERG, ETV1, ETV4 and ETV5), resulting in fusion gene over-expression. The most
prevalent ETS gene rearrangement, which is observed in >50% of PCa, involves the fusion of the androgen
receptor (AR) target gene, TMPRSS2, with the ERG proto-oncogene, resulting in the formation of TMPRSS2-
ERG gene fusion. Defining the mechanisms associated with the formation of recurrent genomic
rearrangements will contribute towards our understanding of PCa etiology and will impact several aspects of
clinical disease management ranging from prevention, early diagnosis and therapeutic targeting. The overall
goal of this proposal is to apply innovative genomics approaches to define the origins of recurrent genomic
rearrangements in PCa. On the basis of our work and the emerging body of scientific literature, we hypothesize
that androgen signaling associated 3D genome organization and transcriptional regulation contribute towards
topological stress in the genome. The enzyme DNA topoisomerase II beta (TOP2B) resolves topological stress
by the formation of transient DNA double strand breaks (DSBs). We suggest that oxidative stress impairs the
function of TOP2B, resulting in the formation of persistent DNA DSBs. Clustering of DNA DSBs in the genome
increases the likelihood of their mis-repair and the formation of recurrent genomic rearrangements. In Specific
Aim 1, we will define the AR-induced, transcription-associated chromatin interactions in PCa models. We will
leverage this knowledge to pinpoint the mechanisms by which germ-line PCa predisposing risk SNPs and
somatic structural variations alter the 3D genome architecture to drive transcriptional dysregulation in PCa. In
Specific Aim 2, we will map the genomic regions associated with topological stress by applying our new
strategy to identify TOP2B occupancy. We will also test the role of oxidative stress and TDP2, a 5-prime
tyrosyl-DNA phosphodiesterase in the formation of TOP2B mediated DNA breaks. Furthermore, we will test the
hypothesis that TOP2B mediated DNA DSBs are non-random and occur at distinct genomic regions in the
various cell types of the prostate—dictated in part by transcription-associated 3D genome architecture.
Therefore, in Specific Aim 3, we will unravel the relationship between prostate epithelial differentiation status
and the formation of TMPRSS2-ERG gene fusions. We anticipate that successful completion of these aims will
enhance our understanding of the origins of recurrent genomic rearrangements in PCa. We believe that our
discoveries in PCa models will have broad implications for many other types of cancers. Importantly, these
studies will serve as the rationale for future clinical trials aimed towards the prevention and treatment of PCa.

Public health relevance
Project Narrative Genomic rearrangements involving the ETS transcription factor family genes are causally associated with the development of prostate cancer. The overall goal of this proposal is to apply innovative genomics approaches to define the origins of recurrent genomic rearrangements in prostate cancer. Defining the mechanisms associated with the formation of recurrent genomic rearrangements will contribute towards our understanding of prostate cancer etiology and will impact several aspects of clinical disease management ranging from prevention, early diagnosis and therapeutic targeting.